A familiar stress in an unfamiliar place: cell wall stressors and bacterial countermeasures in the cytosol

Project Summary
Antibiotic resistance in bacterial pathogens is quickly rendering current antibiotics obsolete; thus, there is a
need to discover additional molecular targets and develop novel strategies for treating bacterial infections. We
have previously determined that the important pathogen and powerful model Listeria monocytogenes (Lmo) is
rendered sensitive to cell wall stress in vitro, including that imposed by β-lactam antibiotics and host-derived
defenses such as lysozyme, upon genetic disruption or pharmacological inhibition of PrkA, a penicillin-binding
protein and serine/threonine-associated (PASTA) kinase. PASTA kinases are activated by disturbances in cell
wall homeostasis and mediate a stress response through largely unidentified phosphotargets and downstream
pathways. PrkA is also required for cytosolic survival of Lmo, suggesting Lmo faces cell wall stress in the host
cell cytosol. While the host cytosol is known to be restrictive to non-adapted bacteria, the cell autonomous
defenses (CADs) responsible for killing bacteria remain largely unidentified. In this proposal, we will test the
hypothesis that PrkA phosphosubstrates mediate cell wall stress responses important for cytosolic
survival and virulence using an orthogonal approach combining genetic and phosphoproteomic
analyses. Furthermore, we will test the hypothesis that the host elaborates cell wall-targeting defenses
against bacteria in the cytosol through a forward genetic screen and parallel untargeted proteomics
approach. Preliminary phosphoproteomic and genetic suppressor analyses of wild-type and ΔprkA Lmo during
β-lactam exposure in vitro revealed that PrkA phosphorylates ~50 proteins, including the broadly conserved
protein of unknown function IreB, during cell wall stress. However, the importance of IreB and other putative
PrkA substrates in the context of the cytosol remains unknown. In this proposal, I will elucidate the function of
IreB, assess its role in Lmo cytosolic survival, and test for functional conservation in other related organisms.
To comprehensively assess the role of PrkA in cytosolic stress responses, I will execute parallel ex vivo
phosphoproteomic analysis and in vivo suppressor selection to identify PrkA targets relevant during infection.
To identify CADs that kill non-adapted bacteria in the cytosol, I will use a genome-wide CRISPR/Cas9
mutagenesis screen and proteomic analysis of Lmo isolated from the cytosol of macrophages to identify host
factors that kill non-cytosol-adapted bacteria. Putative CADs will be validated through standard genetic
approaches, and initial functional characterization will be performed as necessary. Completion of the Aims
herein will provide insights into bacterial adaptations to cytosolic cell wall stress and will identify host factors
that kill maladapted bacteria in this compartment. These studies therefore have the potential to illuminate new
avenues for both pathogen- and host-directed therapies to combat antibiotic-resistant bacteria.

Public health relevance
Project Narrative Antibiotic resistance in bacterial pathogens has become an urgent public health threat, and consequently new approaches for pathogen- and host-directed therapies are needed. The cytosol is an important infection interface that restricts growth of non-adapted bacteria, yet the cell autonomous defenses that protect the cytosol and in turn the adaptations used by professional cytosolic pathogens remain largely unexplored. These studies will identify host factors responsible for killing bacteria in the cytosol and characterize how pathogens adapt to these stressors, with the goal of illuminating new avenues for antimicrobial intervention.